Targeting the DNA Damage Response in CDK12-Mutant Prostate Cancer

PROJECT SUMMARY
Prostate cancer is the second most common cause of cancer death among men in the United States. While
early-stage prostate cancers often respond to hormonal therapy, a subset progresses to an incurable state
known as castration-resistant prostate cancer (CRPC), which is resistant to standard hormonal therapies. New
therapeutic agents for molecularly-defined subsets of CRPC are urgently needed. Mutations in cyclin
dependent kinase 12 (CDK12), a transcription-associated protein kinase, are found in 1-2% of localized
prostate cancer and 6-8% of CRPC. The identification of therapies that are effective in this clinically
aggressive molecular subtype of mCRPC remains a pressing and unmet clinical need.
Intriguingly, mutations in CDK12 are associated with distinctive tumor genomic features, including a
genome-wide pattern of tandem duplications, the amplification of oncogenes, the utilization of cryptic internal
polyadenylation sites, and an increased frequency of gene fusions. Several of these features have been
associated in other contexts with increased DNA replication stress (RS), which arises from aberrant origin
firing or when DNA replication forks encounter DNA damage or stalled transcriptional complexes. Under
normal conditions, the RS response is activated by signaling through the ATR/Chk1 kinase pathway, leading
to coordinated DNA repair events that promote replication fork re-start. Under conditions of elevated RS,
which occur in some cancers, there is increased dependence on ATR/Chk1 signaling for survival. Indeed,
several ATR inhibitors (ATRi) are now in clinical development and have shown promising activity in Phase I/II
trials in unselected populations.
The hypothesis underlying this project is that CDK12-mutant prostate cancer is associated with increased RS,
thereby resulting in a sensitization to ATRi. Through the following aims, we explore the mechanism-driven
application of ATRi and poly(ADP-ribose) polymerase inhibitors (PARPi) in CDK12-mutant prostate cancer.
First, in Aim 1, we use cell line models and immunostaining of prostate cancer tissues to determine whether
CDK12 loss is associated with the increased expression of RS markers. Next, in Aim 2, we test ATRi as
monotherapy or in combination with PARPi in both in vitro and in vivo models of CDK12-mutant prostate
cancer. Together, this exploratory project aims to lay the framework for the design of biomarker-selected
clinical trials of ATRi monotherapy and/or combination therapy for CDK12-altered mCRPC and to influence
clinical practice paradigms for this aggressive subset of mCRPC that is poorly responsive to the current
standard therapies.

Public health relevance
PROJECT NARRATIVE Prostate cancer is the second leading cause of death among men in the United States. Prostate cancers harboring mutations in CDK12 are aggressive and respond poorly to standard therapies. This proposal explores whether CDK12-mutant prostate cancers are sensitive to inhibitors of the ATR kinase.